Protein-Protein Interactions in Natural Product Biosynthesis

Project Summary.
This program investigates the role of protein·protein interactions in carrier protein-dependent biosynthesis,
including fatty acid synthase, polyketide synthase, and non-ribosomal peptide synthetase pathways. The
natural products associated with these pathways serve as therapeutics including antibiotics, antifungals, and
anticancer agents. The ability to direct the biosynthesis of these pathways for the production of untried
bioactive compounds is of critical importance for new and improved therapies. In prior years, we demonstrated
how protein'protein interactions between carrier proteins and partner protein domains direct reactivity and
guide processivity. Moreover, we developed a suite of chemical biology tools to stabilize and interrogate these
interactions at atomic resolution through innovative crosslinker development and structural biology. We now
propose to expand these tools with new, caged crosslinkers designed to capture transient partner proteins.
With this comprehensive library of crosslinkers, we will evaluate carrier protein interactions with partner
proteins that include ketoreductases, enoyl reductases, and thioesterases from fatty acid and polyketide
synthases, ketosynthase/chain-length factors and acyltransferases from polyketide synthases, and
condensation domains, halogenases, and oxidases from non-ribosomal peptide synthetases. Once captured,
these crosslinked species will be studied by solution-phase NMR, kinetic and thermodynamic assays, X-ray
crystallography, and molecular dynamics simulations to more fully elucidate mechanism and specificity
conferred by carrier protein-substrate/intermediate/product interactions. Finally, we will use data collected in
this program as an informatic platform to enable synthetic biological production of new natural product hybrids.
This equiment supplement is requested to improve the scale and purity of prepared probes and expedite our
probe and crosslinker synthesis. Probe and crosslinker purification is one of the largest bottlenecks within our
discovery pipeline, and request for this instrumentation will enhance the rigor of these efforts.

Public health relevance
Project Narrative Natural products provide critical medicines to treat human disease; therefore, an understanding of their biosynthesis will directly support development of new and improved natural product-based therapeutics. Developing on outstanding progress in recent years towards revealing the fundamental protein·protein interactions between biosynthetic enzymes, this proposal aims to further our knowledge through the development of tools to structurally characterize biosynthetic machinery at atomic resolution with temporal acuity. This proposal requests instrumentation to prepare and isolate chemical probes to understand these concepts, which will provide a foundation to rationally manipulate these pathways and afford access to new molecular species for next-generation drug discovery and development.